Leveraging Protein Kinase G-1 Nanodomain Control and Molecular Targeting to Enhance its Therapeutic Use Against Myocardial Disease

The goal of this project is to re-invent concepts regarding the regulation, targeting, and
particularly the translational use of protein kinase G (PKG) activation for the goal of treating
myocardial disease. PKG is the primary enzyme activated by the second messenger cyclic GMP (cGMP)
and a prominent regulator of vascular tone. Its role in the cardiomyocyte has been more
controversial, but growing evidence shows that stimulating PKG provides a potent anti-stress and
pathophysiological brake, countering pro- hypertrophic/fibrotic signaling, mechano-sensing and
arrhythmia, and improving diastolic function. New data from our lab now shows it can also
profoundly impact microRNA formation, protein quality control, and autophagy. Cyclic GMP is
generated by either a nitric oxide or natriuretic peptide signaling-pathway. While both have long
been viewed as interchangeable, our recent work shows prominent differences in their role and
regulation in the cardiomyocyte. They operate in nano-domains regulated by specific phospho-
diesterases; notably PDE5 and PDE9 that target NO and NP stimulated cGMP, respectively. Thus, how
one activates PK effectively depends upon the disease condition and thus how cGMP is being
generated, which PDEs are involved, and even the post-translational state of PKG. For example,
oxidative stress, which depresses NO-stimulated cGMP also oxidizes PKG, which we showed reduces its
protective effects while also altering its response to agonists. Estrogen depletion impairs
NO-stimulated cGMP in females, compromising PKG activation strategies dependent on this pathway.
This R35 program develops four innovative research programs aimed at ultimately improving our
therapeutic use of PKG activation: 1) Dissect nano-domain controls, defining protein partners,
selective PKG kinase targets, their dynamics in varying diseases, and how they can be more
effectively regulated; 2) Identify how co-morbidities such as obesity, metabolic syndrome, and
post- menopause limit PKG activation strategies, and develop methods to circumvent them; 3)
Discover novel signaling by which PKG activation provides benefit, including new roles in
autophagy, proteosome trafficking, pathological mechanosensing and transcriptional controls; and 4)
Develop a PKG proteotype using new proteomic methods applied to human heart biopsies and blood.
Through this work, we aim to transform concepts of PKG therapy for heart disease, based on its
biology to derive an effective personalized approach.

Public health relevance
This program focuses on the control and effective therapeutic use of activating the enzyme PKG1 to treat cardiac muscle disease. The work is multi-scale – ranging all the way from analysis of nanodomains where the enzyme is regulated to its protein interactions, new effects on the heart in health and disease, through to studies of human hearts to determine how it is impacted by heart failure. Using new tools we will decipher how PKG1 is controlled in the heart, and develop a personalized medical approach to its use in patients.